Reducing Infection Susceptibility by Immune Function Restoration in Spinal Cord Injury

Abstract
Acquired infections after spinal cord injury (SCI) are prevalent, constitute the main cause of death in patients
and have been identified as a modifiable risk factor associated with poor neurological and functional recovery.
Infection treatment by orthodox antibiotics is complicated by i) spectrum/efficacy gaps, ii) early development of
antibiotic resistancies, and iii) failure of antibiotics to prevent infections when applied early in patients with
acute CNS lesions. Moreover, new evidence indicates that antibiotics can impair neurological recovery, due to
their ability to cause gut dysbiosis. Improved anti-infective treatment strategies are critically needed, which take
the immune-compromised status after SCI into account. Recent data have identified unregulated sympathetic
tone originating from below the spinal cord injury site (spinally generated sympathetic nerve activity, SNA) as a
major driver of the systemic spinal cord injury immune deficiency syndrome (SCI-IDS). SNA has been
identified and independently confirmed as a mechanistic target to restore immune function in vivo. Three aims
are proposed to answer one main and novel question: Can immune function and host-defense against
pneumonia be re-established with SNA-targeting immunotrophic pharmacological neuromodulation (IPN)?
Experiments in Aim 1 will use a novel combination of FDA-approved drugs selected to promote immune
system function and reduce susceptibility to bacterial pneumonia acutely or at 4 weeks post SCI. Aim 2 will
assess the capacity of IPN to normalize different cellular SCI-IDS characteristics and the sympathetic
neuroendocrine reflex. Irrespective of SCI, infections are well-known causes of dysautonomia, which is a
pathophysiological conduit for septic conversions. Aim 3 addresses whether IPN can blunt infection-associated
autonomic dysfunction and neutralize a sepsis risk factor. If successful, data from these experiments will
directly inform effective non-antibiotic anti-infective strategies for SCI patients to reduce infection-associated
mortality and disability.

Public health relevance
Project Narrative Hospital-acquired pneumonia is predictive of enhanced disability and mortality after SCI; whereas pneumonia qualifies as a potent and targetable outcome-modifying factor, orthodox antibiotic treatments were ineffective to prevent infections or protect outcome at risk. By selecting a mechanistic approach supported by recent data from our lab, we will focus on one goal: Reducing infection susceptibility by restoring immune function. If successful, data from this grant proposal will inform the development of more effective non-antibiotic treatments for immune compromised SCI patients